Reconceptualizing Disease Progression in Pulmonary Fibrosis

PROJECT SUMMARY/ABSTRACT
Pulmonary Fibrosis (PF) is a progressive, fatal lung disease. Two FDA-approved treatments modestly reduce
functional decline but are poorly tolerated and do not relieve symptoms. A major barrier to developing new and
better treatments is that the primary endpoint in clinical trials, change in the forced vital capacity, varies
significantly and is not suitable for early-stage disease. To gain a more complete understanding of progression
across the entire disease development history, the Familial Pulmonary Fibrosis (FPF) Registry was
established. The Registry enrolls proband with clinical (symptomatic) PF and their asymptomatic relatives, who
are “At-Risk” to develop FPF. At-risk relatives participate in an ongoing, prospective study to screen for
progressive subclinical PF. In a preliminary analysis of FPF Registry data, collectively representing early
subclinical through advanced PF, the progressive decline in several pulmonary function tests (PFTs) was
evaluated after disease stage alignment using a Bayesian approach. Counter to the prevailing view that PF
progression is individual-inherent, our data suggests that the rate and timing of progression on various PFTs is
conserved across individuals and highly stage-specific. The diffusion capacity of lung for carbon monoxide
begins declining 10 years before clinical disease onset, while forced vital capacity is normal initially but
declines precipitously 5 years after clinical disease onset. Notably, no PFT parameter declines uniformly
across the disease development history, so any trial whose analysis ignores disease stage will be inherently
inefficient. A Bayesian approach can also be used to conduct a treatment efficacy analysis, measuring the
proportional treatment effect on progression of one or more endpoints, after accounting for disease stage.
Experience with other rare, slowly progressive diseases suggests that this approach can have a huge impact
on trial efficiency. Our hypothesis is that patients with PF experience a conserved, sequenced, and stage-
specific progression trajectory. Specific Aim 1) Fit and validate a Bayesian disease progression model defining
the conserved progression in PF. Domains on which progression is evaluated will include physiological (PFTs),
anatomical (quantitative lung imaging), and biological (circulating biomarkers). Aim 2) Test the utility of
incorporating a Bayesian approach to PF trial design. The results of Aim 1 will be used to design trials with
stage-specific population selection criteria, stage-appropriate endpoint(s), and/or a Bayesian statistical
approach to account for disease stage. The operating characteristics (trial size, type 2 error) will be simulated
and compared to traditional trial designs. Trial designs applicable in both subclinical and clinical disease will be
simulated. These transformative results will ultimately lead to more effective therapy for this devastating
disease by: 1) proposing novel trial designs that substantially improve trial efficiency; 2) enabling disease
prevention trials; and 3) providing a template to understand the optimal timing of treatment initiation, ultimately
supporting earlier diagnosis of PF.

Public health relevance
PROJECT NARRATIVE Developing new and better therapies for pulmonary fibrosis would address a critical unmet need to reduce the substantial burden of progressive symptoms and high mortality for patients. The current approach to clinical trial design is inefficient, impeding progress toward this goal. Using a novel approach to understand the conserved rate and timing of progression on key disease status domains in pulmonary fibrosis (physiological, anatomical, and biological), this project will develop trial designs that can capture progression and determine treatment efficacy more efficiently and across the whole disease development history.